Translating Individual-level Risks and Preferences Into Personalized Blood Pressure Target Decisions

PROJECT SUMMARY
Simon Ascher, MD, MPH is establishing himself as a clinical investigator in patient-oriented research that
focuses on individualizing clinical decision-making in hypertension. This K23 award will provide the necessary
training for Dr. Ascher to successfully transition to an independent investigator and achieve the following goals:
1) develop expertise in advanced statistical methods for predicting individualized treatment effects from clinical
trials; 2) acquire essential knowledge and skills in using surveys to quantify patient preferences; 3) obtain
hands-on experience in developing patient decision aids embedded in the electronic health record (EHR); and
4) gain proficiency in designing and conducting behavioral clinical trials. Dr. Ascher has assembled a
mentorship team led by his co-primary mentors, Dr. Richard Kravitz, an established leader in doctor-patient
communication and heterogeneous treatment effects; and Dr. Michael Shlipak, an internationally renowned
researcher in kidney and cardiovascular disease epidemiology, and comprised of co-mentors and advisors
who provide complementary expertise in advanced biostatistics methods, health preferences, digital health,
and clinical trials. Hypertension affects nearly half of all U.S. adults, yet optimal blood pressure (BP) targets
continue to be heavily debated and poorly implemented. The Systolic Blood Pressure Intervention Trial
(SPRINT) demonstrated among non-diabetic individuals that intensive BP treatment reduces CVD events and
deaths, but also increases serious adverse events. The broad application of SPRINT could have enormous
public health impact, but well-documented heterogeneity in risks and preferences requires individualized
decision-making. Building on Dr. Ascher's KL2-supported work, the current proposal aims to develop a
personalized approach to BP targets by combining several powerful strategies: individualized risk prediction for
multiple outcomes, calibration of the benefits and harms from BP treatment according to patient preferences,
and use of a BP target decision aid to guide shared decision-making. In Aim 1, he will refine models in SPRINT
that predict for each outcome an individual's change in absolute risk with intensive versus standard BP
lowering and then seek external validation in the Action to Control Cardiovascular Risk in Diabetes Blood
Pressure (ACCORD BP) trial. In Aim 2, he will use an instrument he previously developed to characterize the
variation in patient preferences for BP treatment outcomes, and to identify a limited set of patient clusters with
similar preferences. In Aim 3, he will first develop an interactive BP target decision aid embedded in the EHR
that translates a patient's risks and preferences into a personalized BP target recommendation; he will then
evaluate the decision aid's feasibility in a pilot trial. The proposed plans are realistic and feasible within the 5-
year award period, and will lay the groundwork to pursue funding to conduct a large-scale trial of the BP target
decision aid. In addition, Dr. Ascher will have acquired the skills and experience necessary to achieve his
career goal of becoming a leader and innovator in efforts to individualize CVD prevention strategies.

Public health relevance
PROJECT NARRATIVE Hypertension is one of the most common chronic conditions among adults, and optimizing blood pressure treatment strategies could have an enormous public health impact. This proposal aims to develop an innovative, personalized approach for making decisions about blood pressure treatment targets for adults with hypertension that is based on each person's medical history and personal preferences. This information will be built into a decision aid in the electronic health record that provides a customized recommendation to help guide individuals with hypertension and their providers in choosing the optimal blood pressure treatment target.